Molecular architecture of the Vaccinia virion by structural proteomics

The poxviruses comprise a major virus family of medical, ecological and agricultural importance.
The most notorious family member, smallpox has been one of the great killers of mankind.
Although the disease was eradicated some 40 years ago, the possibility of smallpox re-
appearance at some future time has increased immeasurably with the recent demonstration that
a poxvirus very similar to smallpox could be recreated de novo, in the laboratory, with ease.
Moreover, eradication and the cessation of vaccination has coincided with the appearance of
feral human poxviruses including human monkeypox in Africa, the US and UK. Not knowing the
lethal factor in smallpox, the full potential of such outbreaks remains uncertain. The importance
of virus envelope and capsid proteins in mediating the effects of antiviral therapeutics and
vaccines is undisputed. For small RNA viruses in particular, an understanding of virion structure
at molecular or atomic resolution has instructed the development of therapeutic agents and an
understanding of mechanisms of infection and disease. Due to their complexity, asymmetry and
heterogeneity, poxvirus virions have, however, persistently eluded attempts to elucidate their
molecular structure, closing a potential avenue of rational design and intervention. The P.I.
hypothesizes that the relative complexity of the vaccinia virion may be a therapeutic Achilles
heel. Moreover, a molecular-level understanding of virion morphogenesis and organization, one
of the last remaining black boxes in the lifecycle of the poxviruses, impinges upon at least five of
the seven classical stages of virus replication. A major gap in our knowledge of pox virion
structure lies at the level of molecular architecture – an intervening organizational level between
ultrastructural features and the inventory of protein molecules contained within the virion. The
P.I. has successfully applied a protein-protein chemical crosslinking approach in combination
with protein mass spectrometry (XLMS) to discover neighboring proteins and domains within the
undisrupted vaccinia virion in situ. Aim 1 of this proposal seeks to deepen the XLMS dataset to
a level that will allow protein molecular docking. Combining XLMS with mutant virus particles
blocked in morphogenesis and displaying no apparent internal organization, Aim 2 of this
proposal asks whether the virion morphogenic pathway follows a classical programmed linear
hierarchy or a process of self-organization with no single, dominant route from molecular
components to assembled virion. Using “QconCAT” quantitative MS, Aim 3 seeks to convert
XLMS data to a molecular model by determining the global stoichiometries of virion proteins.

Public health relevance
Outbreaks of harmful viruses such as Ebola and Zika can rapidly threaten global human health. Although one of the most catastrophic diseases of mankind, smallpox was eradicated 40 years ago, a very similar poxvirus was recently constructed in the laboratory de novo as a proof of principle, and natural outbreaks of poxvirus disease due to animal-human transmission have recurred throughout the past 40-years. This grant proposes new and promising approaches to understand the three-dimensional molecular structure of the virus at the heart of all smallpox vaccines, a virus "seen" in three-dimensional form by the immune system and which contains potential three-dimensional targets for drugs, yet whose three-dimensional structure remains almost entirely unknown.